Recombineering-based no-cleavage gene-editing toolkit for large-scale genome engineering and functional screening

Project Abstract
Recombineering-based no-cleavage gene-editing toolkit for large-scale genome engineering
and functional screening
Exemplified by the CRISPR-Cas9 system, gene-editing technology is a powerful collection of
tools for probing the hidden mechanisms of human diseases by understanding and controlling
the functions of human genome variants. Limitations of existing CRISPR tools stem from two
sources: 1) Cas9 cutting causes uncontrollable DNA damage at on/off-target sites, leading to
toxicity and stress response. Recent studies confirmed that cutting-induced damages lead to
significant gene expression changes and enrichment of p53-mutant cells, thus confounding
some CRISPR screens; 2) CRISPR enzymes do not repair the target DNA, thus relying on
endogenous DNA repair to complete editing. This results in low efficiency and high variability for
Cas9-mediated homology-directed repair (HDR) across cell types and models. To overcome
these limitations, we have identified a recombineering-based gene-editing tool, termed RecE/T-
induced Editing via Designer-Cas9-Initiated Targeting (REDIT). REDIT uses deactivated Cas9
(dCas9) and generates minimal DNA break and near-zero toxicity. REDIT uses phage
recombineering proteins RecE/T for gene-editing, bypassing the dependence on endogenous
repair mechanisms. Our proof-of-concept demonstration showed that REDIT achieved efficient
kb-scale editing without DNA cutting. We will focus on technology development and validation
with well-characterized models using gold-standard assays. The proposed RecE/T-like
recombineering proteins present new opportunities as they promote strand invasion/exchange
without cleavage when genome sites become transiently accessible via dCas9 DNA-unwinding.
Our goal is to develop a safe, scalable toolkit with up to 80% HDR efficiency for kilobase gene-
editing and pooled knock-in screening.

Public health relevance
Project Narrative Recombineering-based no-cleavage gene-editing toolkit for large-scale genome engineering and functional screening As gene-editing tools help unravel mechanisms of biological process such as tissue development and human diseases such as cancer, a remaining challenge is that our current gene-editing tools are often limited to making small genome changes like single-nucleotide variants. The key bottleneck is the lack of efficient, safe, and robust tools to study large genome changes. Thus, it demands new modalities of genome engineering tools that we proposes to develop here, leveraging novel class of no-cleavage recombineering-based mechanisms, pushing our ability to engineer, track, and control cellular genomes and proteomes.